Thiol mediated redox homeostasis in Haemophilus influenzae biofilms

PROJECT SUMMARY/ABSTRACT This application is for an RO1 project focused on defining determinants of bacterial persistence in biofilms during otitis media infections. Otitis media is caused by airway opportunists such as Haemophilus influenzae (Hi), which forms multicellular biofilm communities that promote bacterial persistence within the middle-ear chamber. Over the past 15 years we have defined mechanism(s) involved in biofilm formation by Hi, proved that biofilms promote bacterial persistence in vivo, and defined metabolic determinants of Hi persistence within biofilm communities. Now, we plan to use this information to better understand the metabolic state of Hi bacteria within biofilms, and to use that information to identify enzymes important to glutathione mediated redox homeostasis to eradicate Hi bacteria within biofilms. In particular, we will ask how glutathione contributes to Hi persistence in the face of chronic oxidative stress. We will complete the following Specific Aims: Specific Aim 1. To define role(s) for glutathione uptake and metabolism in Hi survival in biofilms. Specific Aim 2. To test role(s) for glutathione mediated redox homeostasis in Hi persistence in vivo. Although it is clear that the biofilm mode of growth is involved in the majority of persistent infections, much remains to be learned about the determinants of bacterial resistance to clearance within biofilms. The completion of the proposed work will enhance our understanding of the role of biofilms within the clinical context of otitis media.

Public health relevance
PROJECT NARRATIVE Otitis media is a major common and costly pediatric illness worldwide, accounting for billions of dollars per year in total economic impact. Otitis media infections are the leading reason for pediatric office visits, new antibiotic prescriptions, and surgical instillation of tympanic drain tubes to relieve chronic and recurrent otitis media is the most commonly performed surgical procedure in the U.S. Haemophilus influenzae has long been recognized as a common bacterial cause of otitis media, and our work on this project has been highly enlightening with regard to learning how these bacteria form biofilms in vitro and in patient tissues. The focus of this application is to using this knowledge to focus on glutathione mediated redox homeostasis as a key metabolic determinant of bacterial persistence during the biofilm state. This pathway may therefore represent an important “Achilles' heel” that could be exploited for development of new therapeutics.